Smart Laser Capturing Microscope for Genome Wide Single Cell Spatial Transcriptomics

PROJECT SUMMARY
We introduce an innovative AI-Assisted Laser Capture Microdissection (AI-LCM) approach for Spatial
Transcriptomics, designed to overcome the limitations of existing spatial biology methods. Current techniques
like MERFISH, Visium, and traditional LCM have distinct strengths, but they fall short in providing both single-
cell resolution and genome-wide coverage efficiently. Our AI-LCM technique combines microscopy, Next
Generation Sequencing (NGS), and LCM to enable high-throughput, comprehensive spatial transcriptomics
analysis. Our method utilizes DNA nanoballs tagged with unique molecular identifiers (UMIs), readable via both
microscopy and NGS. This dual-readout allows for an 'imaging-followed-by-sequencing' workflow, ensuring each
cell's omics profile is linked to its spatial coordinate through the UMI-tagged nanoballs. We will achieve this
through three strategic aims: 1. Optimizing in situ generation and sequencing of DNA nanoballs for diverse
sample types. 2. Enhancing AI-assisted LCM to efficiently dissociate nanoball-tagged single cells at high-
throughput. 3. Refining sequencing protocols to accommodate nanoballs, linking genomic data with precise
spatial origins. This approach promises true single-cell spatial resolution with genome-wide coverage, exploiting
the dual-functionality of DNA nanoballs for concurrent processing of thousands of cells, vastly improving LCM's
throughput. Building on established technologies, our protocol is both feasible and innovative. DNA nanoballs
are already integral in microscopy-based spatial transcriptomics, and LCM's robustness for single-cell profiling
is well-documented. Our integration of microscopy and genomics draws on the PIs' extensive experience in
commercial SBS products, automated microscopy, and AI-based image analysis. The proposed AI-LCM method
not only aims to transcend the boundaries of existing spatial transcriptomics but also seeks to expand the
possibilities for a wide range of single-cell assays, adding valuable spatial context to complex genomic data.
This project stands to revolutionize the field by providing a novel tool for comprehensive, high-resolution mapping
of cellular environments.

Public health relevance
PROJECT NARRATIVE We aim to add a spatial coordinate to existing single-cell RNA sequencing techniques, thereby achieving single- cell resolution and genome-wide coverage for spatial single-cell transcriptomics. This can enhance our understanding of cells and their interactions, as well as diseases like cancer. Such research could lead to deeper insights into living systems, potentially resulting in improved health outcomes and longer lifespans.